Disrupting the Fibrin Shield to Combat Staphylococcus aureus Bloodstream Infections

ABSTRACT
Staphylococcus aureus (S. aureus) is a leading causative agent of life-threatening bloodstream infections. The
increasing prevalence of antibiotic-resistant strains (e.g., methicillin-resistant S. aureus), as well as understudied
mechanisms of antibiotic tolerance, highlights the necessity of identifying strategies to better combat S. aureus
virulence. Fibrinogen is a monomeric plasma glycoprotein which polymerizes to form a fibrin matrix following
proteolytic cleavage by the coagulation protease thrombin. The physiological role of fibrin(ogen) is in hemostasis
and vascular repair following blood vessel injury. However, S. aureus has evolved an extensive repertoire of
virulence factors that engage host fibrin(ogen), including the bacterial coagulases ‘staphylocoagulase’ and ‘von
Willebrand factor-binding protein’ that hijack host prothrombin to catalyze fibrin polymerization. The coagulases,
along with key bacterial fibrin(ogen)-binding proteins (FBPs; e.g., clumping factor A) support the formation of a
‘fibrin shield’ around the pathogen to promote protection from the host and antibiotic therapies in the bloodstream.
The central hypotheses of this proposal are that (i) S. aureus fibrin shield formation and function is driven by
bacterial binding of circulating fibrinogen followed by coagulase-mediated fibrin polymerization, and that (ii)
disruption of fibrin shield formation with novel fibrinogen variants (e.g., nonpolymerizable or non-S. aureus-
binding variants) will result in increased bacterial susceptibility to antibiotic treatment during the course of a
bloodstream infection. Preliminary in vitro studies suggest collaborative roles for each coagulase and other FBPs
in fibrin shield formation. Moreover, a major mechanism of protection induced by the fibrin shield is induction of
an antibiotic-tolerant state. In vivo studies support critical roles for coagulases and FBPs in S. aureus virulence
in a murine model of intravenous infection and demonstrate the capacity for fibrinogen variants to disrupt
fibrin(ogen)-dependent S. aureus virulence and improve host infection outcomes. The studies proposed will 1)
determine the contribution of S. aureus-mediated fibrin(ogen) binding and fibrin polymerization to pathogen
virulence in the bloodstream and 2) evaluate the efficacy of fibrinogen variants, which lack key S. aureus binding
motifs, in disrupting S. aureus fibrin shield formation in vivo as a therapeutic strategy to increase bacterial
susceptibility to antibiotic therapies. In vitro analyses of fibrin shield formation and function, mechanisms of
fibrin(ogen)-mediated S. aureus antibiotic tolerance, and in vivo murine models of bloodstream infection will build
upon preliminary results to rigorously investigate the role of fibrin shield formation in S. aureus pathogenicity and
antibiotic tolerance as well as examine the potential for novel fibrinogen-directed therapeutics in improving
infection outcomes. The UNC Blood Research Center, Department of Biochemistry and Biophysics, and
Integrative Vascular Biology Training Program (NIH T32 fellowship) provide an outstanding environment to
successfully complete the proposed work. The completion of this F31 fellowship will play an instrumental role in
reaching my goal of becoming an independent researcher.

Public health relevance
PROJECT NARRATIVE The bacterial human pathogen Staphylococcus aureus can cause life-threatening illnesses following infiltration into the blood. This proposal will define the molecular details and pathological consequences of interactions between S. aureus and the blood clotting protein fibrinogen that help the bacteria evade antibiotic treatments. Successful completion of planned work will lay the foundation for use of novel fibrinogen-based therapeutic strategies that reduce bacterial virulence and increase antibiotic efficacy against S. aureus bloodstream infections.